RCMI Administrative Core

SUMMARY – ADMINISTRATIVE CORE
The Administrative Core (AC) will manage, coordinate, and support RCMI program activities. Working closely
with the RCMI Coordinating Center and directed by three MPIs, the AC will provide administrative and logistical
support to assure core directors and faculty are fully engaged in communicating and building strategic
partnerships. The integrative leadership structure is purposely designed to ensure that core activities are
successfully implemented in a seamless and cohesive manner. This is accomplished by identifying and
deploying relevant resources and implementing common metrics all focused on optimizing the institutional
research infrastructure that drives PI productivity. The AC will accomplish the following aims: Aim 1. To provide
effective leadership in managing the key activities of the RCMI program. The AC management team will
consist of three MPIs, Core Directors, and Program Managers. The AC will have monthly meetings to review
progress, identify problems, discuss and implement solutions and improvement plans to ensure that each
program goal is achieved as measured by assessment milestones; In addition, working with Xavier’s Office of
Research and Sponsored Programs (ORSP), the AC will manage, review and approve all human subjects
research conducted within RCMI. Aim 2. To implement processes for efficient use of the research capacity
core facilities. The AC will have regular meetings with the core faculty expertise group to review core
operations, policies and procedures. Quarterly core service surveys and quarterly core service reports will be
collected which track user satisfaction, core efficiency, and outcomes as measured by core-citing publications
and grant applications with core participation. Aim 3. To provide administrative assistance in developing
successful grant proposals for external support. The AC will work collaboratively with Xavier’s ORSP to provide
a unified research faculty support mechanism focused on increasing the volume of extramural grants and
contracts applications. In a highly coordinated effort, ORSP and AC staff will identify potential funding sources,
provide professional proposal review, provide financial and logistic support to a network of mentors for pilot
projects and early-stage investigators in developing grantsmanship, and assist faculty in the administration of
their grants; Aim 4. To promote and facilitate the recruitment, development and retention of a diverse pool of
investigators actively engaged in health disparities research. The AC will work with academic administrators to
promote the recruitment of minority faculty and through the Investigator Development Core, assist in acquiring
the resources early-stage faculty need and finding for them collaborators and mentors. Aim 5. To implement
the RCMI Program evaluation plan. The AC will coordinate with the RCMI Advisory Committee, the Community
Advisory Board, and the Independent Evaluator to implement the comprehensive evaluation of the RCMI
program in enhancing research capacity to facilitate health disparities research, increase productivity of
investigators in peer-reviewed publications and overall success in securing extramural research funding.